EFFECTS OF INTRAVENOUS COCAINE ON REGIONAL CEREBRAL ACTIVITY MEASURED BY FMRI

This investigation attempts to determine the sites of action of cocaine in the brain and to understand how this drug alters regional brain activity associated with the performance of attention and memory tasks.